Core 2: Administration Core

The Core will be physically located on the second floor of the Roosevelt 1 BIdg, in the Offices of the UW Department of Environmental and Occupational Health Sciences. Dr. Kavanagh, Dr. Eaton and Dr. Faustman have their offices and laboratories on the same floor in this building along with most of the other faculty in the Toxicology Program. This building also houses the Center for Ecogenetics and Environmental Health (CEEH) and the core services and laboratories for the Toxicology Program. Dr. Kavanagh will serve as the PI for Core 2, and will be responsible for oversight for budget expenditures and administrative responsibilities of the core. He will supervise the activities of Ms. Tuthill and Fritzen in matters of administration, budget and fiscal management, web-site design and maintenance, and report generation. Ms. Cody Tuthill, Program Coordinator for the Core, is currently Program Coordinator for the Toxicology Program in DEOHS. She has more than 5 years of experience in program management, travel reimbursement, fiscal management and web-design. She will be the point of contact between core project directors will maintain the Program electronic calendar for organizing meetings, journal clubs, etc. and edit the UW Nanotox Blog pages. Ms. Geralyn Fritzen, Budget/Fiscal Analyst, has over 25 years of experience in clerical and administrative duties and is fully familiar with UW and NIEHS budgeting procedures. She will work closely with Ms. Tuthill and assist Dr. Kavanagh with day-to-day operations of the Core in regards to fiscal matters and filling in with other responsibilities as necessary.